Role of Kidney Proximal Tubular Secretion in Critical Illness

Project Abstract
Acute kidney injury (AKI) is one of the most common types of organ dysfunction among persons in the
intensive care unit (ICU). Most causes of AKI involve injury to the proximal tubules of the kidneys. However,
clinical evaluation of AKI relies on measurements of serum creatinine as a marker of glomerular filtration.
Consequently, the severity and clinical implications of AKI may be misaligned with the biology of the disease.
Proximal tubular secretory clearance is rarely measured due to a lack of reliable methods and uncertainty
regarding clinical interpretation. We developed a novel targeted mass spectrometric assay to estimate tubular
secretory clearance based on quantification of endogenous secretory solutes in plasma and urine, and we
demonstrated that tubular secretory clearance is associated with the progression of chronic kidney disease
and mortality independent of the estimated glomerular filtration rate.
The general goal of this application is to advance clinical assessment of AKI by adding functional
measurements that align with the underlying mechanisms of disease. We propose to measure tubular
secretory clearances in a prospective cohort of critically ill adults who are at high risk for developing AKI. We
will assess potential shared and unique risk factors for decline in tubular secretion and glomerular filtration,
determine whether tubular secretory clearance adds to the prediction of measured drug levels, and test
whether lower secretory clearance is associated with ICU delirium, coma and the severity and prognosis of
AKI.
1

Public health relevance
Project Narrative Acute kidney injury (AKI) is a common and serious complication of critical illness that primarily affects the proximal tubules of the kidneys. We have developed a new test to measure kidney tubular secretory clearance, which may be most susceptible to impairment in AKI. We propose to measure tubular secretory clearance in patients with critical illness who are at high risk for AKI and we will determine whether this essential kidney function is related to clinical outcomes in the intensive care unit, including medication dosing, delirium, coma, and the prognosis of kidney injury. 1